Defining human interferon-stimulated genes with novel functions in host defense to Chlamydia infections

ABSTRACT
Chlamydia trachomatis is the most widespread sexually transmitted bacterial pathogen in the world.
People infected with C. trachomatis are often initially asymptomatic, hindering the proper diagnostic and
therapeutic strategies necessary to impede this “silent epidemic”. If not properly treated, the bacteria are able
to establish a long-lasting, persistent infection that can ultimately lead to severe medical sequelae. These
complications arise predominantly in women, and include pelvic inflammatory disease, life-threatening ectopic
pregnancies or infertility. A critical component of the microbial pathogenesis of C. trachomatis is its ability to
evade immune detection and other antimicrobial responses conferred by its human host. These host defenses
are largely galvanized by the cytokine interferon-gamma (IFNγ), which stimulates epithelial cells occupying the
site of an infection to up regulate the expression of interferon-stimulated-genes (ISGs). These ISGs are then
responsible for the execution and immune clearance of invading microbes. In order to subvert the effects of
IFNγ and successfully replicate in epithelial cells, C. trachomatis must have evolved counterdefenses to ISGs
that normally target and destroy other bacterial pathogens. However, the identity and function of these ISGs,
as well as the C. trachomatis virulence effectors that inhibit ISG functions, are poorly understood. In pursuit of
answering these questions, we performed two complementary screens to identify i) ISGs with anti-Chlamydia
activities and ii) C. trachomatis genetic mutants with hypersensitivity to IFNγ treatment. In Aim 1 of this
proposal, we will use a combination of functional genetics and cell biological studies in human cells to dissect
the intracellular responses conferred by these anti-Chlamydia ISGs. In Aim 2, we will combine parallel
approaches in bacterial genetics and whole-genome sequencing to pinpoint the causative genetic elements
responsible for C. trachomatis evasion of IFNγ-mediated immunity. Taken together, these experiments will
interrogate the dynamic relationship between cell-intrinsic defenses mediated by human ISGs and counter-
resistance mechanisms of Chlamydia that are employed during infection. Implications of these studies will
provide important platforms for the development of novel anti-Chlamydia medicines or vaccination strategies
that treat its associated disease.

Public health relevance
PROJECT NARRATIVE This project seeks to examine the host-pathogen interactions that underlie Chlamydia trachomatis pathogenesis in human cells. We will examine a branch of human innate immunity that targets intracellular microbial pathogens, as well as the co-evolved C. trachomatis genetic traits that specifically circumvent these cellular defense circuits. The completion of this project will have important translational implications in the development of improved prophylactics and therapeutics against the emerging epidemic caused by C. trachomatis infection.